Brain networks for reading in stroke alexia and typical aging

ABSTRACT
Our active grant, Brain Networks for Reading in Stroke Alexia and Typical Aging, is designed to examine the
brain and cognitive bases of reading. This supplemental project employs the techniques already in place
in the parent grant to examine the neurocognitive basis of reading decline in people with primary
progressive aphasia (PPA), a disorder most commonly associated with frontotemporal dementia or
Alzheimer’s disease. The ability to read is fundamental to living in modern society. Loss of reading ability due
to stroke, head injury, or dementia, called alexia, affects millions of Americans at any given time and causes
difficulty performing many daily life functions. To improve diagnosis and treatment of alexia, we must
understand the neurocognitive basis of reading. In the parent grant we are conducting a large study of both
stroke alexia and typical reading in older adults, using detailed measures of reading ability and the most
advanced multimodal neuroimaging methods available. Reading relies on brain networks that evolved for
speech and language processes, but neurocognitive models of reading have not yet incorporated recent
advances in our understanding of these networks. The parent grant proposes a new model of Reading
Integrated with Speech and Semantics (RISS) that provides a more specific neurocognitive architecture for
reading than prior models. The RISS model articulates the important role that semantics must play in reading.
Semantic processing is hypothesized to rely heavily on activation of the left anterior temporal lobe (ATL).
However, it is difficult to examine the ATL using BOLD fMRI in neurotypical adults due to its close proximity to
the sinuses; and the ATL is rarely damaged by stroke. A significant advantage of studying reading in people
with primary progressive aphasia is that this population includes people whose atrophy is largely focused in
the anterior temporal lobe of the left hemisphere. In fact, a particular pattern of alexia, called surface alexia,
has been linked to a particular variant of PPA, semantic variant PPA (svPPA). Atrophy in svPPA tends to be
focused in the ATL. Yet it is important to note that patterns of alexia, including surface alexia, can be seen in all
variants of PPA, with atrophy observed in other regions of the left hemisphere. Combining results from this
supplement with results from the parent study, then, will provide a more global perspective of how reading is
represented in the brain. The past decade has seen an increase in the number of studies designed to develop
treatments for language impairments in dementia. Most of these studies target word finding impairments, and
some focus on increasing fluency. Reading impairments in dementia have received little attention. By
advancing our understanding of the neurocognitive basis of alexia in dementia, this project will pave the way
for developing effective treatments for alexia in stroke and in dementia.

Public health relevance
PROJECT NARRATIVE Loss of reading ability due to stroke, called alexia, likely affects over a million Americans at any given time and causes difficulty performing many daily life functions. Understanding the brain and cognitive basis of alexia could improve diagnosis and treatment of this important disorder, but modern methods and larger sample sizes are needed to address this gap in knowledge, along with an improved understanding of the brain and cognitive basis of reading in typical older adults in whom stroke is most common. In this project, we will perform a large- scale behavioral and brain imaging study of stroke survivors and typical older adults to improve our understanding of the brain and cognitive basis of reading in both of these groups.